Improving the dose efficiency of photon counting CT

PROJECT SUMMARY/ABSTRACT
Radiation dose is a major drawback of computed tomography (CT) imaging. While the long-term effects of
radiation are difficult to quantify, there is a continued desire to reduce radiation dose through technical
improvement. In theory, photon counting detectors (PCDs) provide several opportunities to reduce CT radiation
dose. In practice, however, PCD CT scanners today have shown only modest gains in dose efficiency
compared to scanners from prior generations for most scanning protocols. Several components of the CT
scanner must be re-engineered to benefit from the dose saving potential of PCDs. The objective of this work is
to perform this re-engineering by designing new components that can take advantage of radiation dose
reduction opportunities with PCD CT.
In Specific Aim 1, we will develop hardware that could improve quantum efficiency, or the fraction of incident
photons that are successfully detected. Today, about 40% of the x-rays that arrive at the detector are never
absorbed by the sensor. 30% of the x-rays are stopped by the anti-scatter grid, and 10% of the x-rays
penetrate the sensor without interaction due to the relatively low stopping power of the sensor. First, we will
experimentally demonstrate a lightweight, striped anti-scatter grid that will increase the number of primary
photons detected while providing a means for estimating residual scatter. The geometry of this grid introduces
striping in the detector signal, with stripe contrast proportional to the level of remaining scatter. Therefore, the
images themselves will contain a means to subtract the remaining scatter. Second, we will develop a guardrail
that can fluoresce a fraction of the punch-through photons and return them to the sensor. We will demonstrate
the guardrail experimentally in a CdTe benchtop PCD.
In Specific Aim 2, we turn to spectral nonidealities in PCD CT. PCDs suffer from pulse pileup and charge
sharing. We will experimentally test a pileup detection circuit that reroutes suspected pileup events into
separate counters. We show that this substantially reduces the impact of pileup and will simulate its use
together with charge summing modes to reduce charge sharing effects. Historically, charge summing modes
have not been used in CT applications because of their pileup penalty. We hypothesize that this mode could
be enabled by stronger pileup corrections, such as the one we will demonstrate. Charge summing modes also
improve dose efficiency for grayscale (non-spectral) tasks by eliminating double counting effects.
Successful completion of these Aims could allow PCDs to unlock their dose reduction potential and could
improve the dose efficiency of PCD CT by 40% for non-spectral imaging tasks and 200% for spectral imaging
tasks.

Public health relevance
PROJECT NARRATIVE Radiation exposure is a major concern for CT imaging. Photon counting detectors provide ample opportunity for reducing radiation exposure, but systems today have not capitalized on this opportunity because it requires redesign of existing CT scanner components. Our work will lay the theoretical foundation and provide experimental demonstration of new scanner components that will allow future photon counting CT scanners to reduce radiation exposure without reducing image quality.